Strong Foundations: Intervening to Promote Co-Parenting and Reduce Father Hazardous Drinking in Expectant Parents

PROJECT SUMMARY/ABSTRACT
This is a multi-method, randomized efficacy trial to promote adjustment, co-parenting, and dyadic functioning
among expecting couples with heavy drinking fathers and mothers who are light drinking/abstaining during
pregnancy. We propose to harness the power of the transition to parenthood as a motivating event providing
opportunity for lasting behavioral change. We will examine the efficacy of an innovative prevention strategy
(mFF+) that adapts and integrates two evidence-based interventions: 1) Family Foundations (FF) - a universal
intervention that has demonstrated meaningful, broad, and durable impacts in universal samples on parent
mental health, parenting quality, and couple relations, as well as infant outcomes in multiple trials and 2) brief
alcohol intervention (BI) for heavy drinking fathers. This modified intervention (mFF+) is a multi-modal
intervention that incorporates alcohol-related content into existing modules of FF and adds a brief intervention
for heavy drinking. Expecting couples (n = 180 couples) will be recruited during the first trimester of their
pregnancy and randomized into either the mFF+ or control condition. The control condition (CC) will consist of
brief advice regarding alcohol use (individualized) and group workshops on community resources and child
development taken from Healthy Families intervention, thereby matching the context and delivery of mFF+ and
controlling for attention. Existing FF modules will be modified to include alcohol content with discussions
around alcohol effects on co-parenting and couple relationship. The adapted mFF+ sessions will be
administered in a group format with 5 prenatal classes and 4 postnatal classes. The BI component will be
delivered in the original individualized format across three meetings: after the baseline assessment, after the
first FF group prenatal session, and approximately 1 month after birth. Our major goal is to examine the
efficacy of this modified intervention, mFF+, in reducing fathers' drinking and couple conflict while promoting
co-parenting quality, parental sensitivity, and child outcomes among families with heavy drinking fathers. There
are two major aims: 1) to conduct a RCT of mFF+ with 180 couples (90 in each condition) with heavy drinking
men and light drinking/abstaining women recruited in the first trimester of pregnancy. Parent reports and
observational assessments of family functioning will be conducted at baseline (pretest), 6 months postpartum
(posttest), and 12 months postpartum (follow-up); 2) to examine whether these impacts on drinking, co-
parenting, adjustment, and couple dyadic functioning mediate the impact of mFF+ on parenting, and infant
outcomes. This application will advance two major initiatives of the National Institutes of Health: effective
intervention for problem alcohol use and prevention of children beginning and continuing to drink alcohol.

Public health relevance
PROJECT NARRATIVE Rates of hazardous drinking among expectant fathers are alarmingly high (27%) and have cascading effects on family processes, parenting, and child development. We propose to prevent this cascade of risk processes in a randomized efficacy trial combining two evidence based interventions beginning in pregnancy: brief alcohol intervention to reduce fathers' hazardous drinking and support abstinence among mothers, and modified Family Foundations intervention to enhance co-parenting and couple dyadic functioning, with cascading effects on parenting quality and infant outcomes. Targeting intervention during the naturally motivating transition to parenthood may not only provide opportunities for long lasting behavioral change, but also initiate a cascade of protective processes that ultimately reduce problem behaviors, underage drinking, and substance use among children of heavy drinking fathers.